GENDER DIFFERENCE IN FUEL METABOLISM DURING/FOLLOWING ENDURANCE EXERCISE

This study aims to determine if fat utilization is greater in females, compared to males, during endurance exercise and whether or not this difference is maintained in the immediate post-exercise period. Both aerobically trained and untrained subjects are being studied to determine any interaction between gender and training status on fuel metabolism.